IGF::OT::IGF OTHER FUNCTIONS. EDUCATIONAL BOOKMARKING TO DEVELOP INTERPRETIVE CUT SCORES FOR PRO-CTCAEL TASK ORDER #20

The contract focuses on scientific and strategic planning, analysis, management, evaluation, and consultation; communication coordination, liaison, and technical services; and scientific liaison and coordination of large research centers.